Ethnic Differences in Iron Absorption

Iron deficiency remains the most widespread micronutrient deficiency worldwide, whereas Fe overload has
been increasingly appreciated as a contributor to many types of chronic disease, such as type II diabetes,
cirrhosis, cancer and cardiomyopathy. We hypothesize that evolutionary adaptations in genes involved in non-
heme Fe metabolism, in East Asian populations, have resulted in an increased efficiency of Fe absorption
even in the face of adequate Fe stores. Our preliminary data from multiple GWA studies on blood Fe status in
populations of European and/or East Asian genetic backgrounds, found novel and statistically significant
enrichment for associations with Fe status in other genes that have been shown to regulate Fe via multiple
biological pathways, suggesting a highly polygenic genetic architecture underlying Fe absorption and
regulation in humans. The enrichment of associations of variations in these genes with blood Fe status at a
pathway level implies that genetic variation affecting Fe absorption and regulation has yet to be exhaustively
identified. We propose to employ a direct functional measure of an individuals' capacity to absorb and
utilize non-heme Fe to build an unbiased genetic architecture of (non-heme) Fe utilization in humans. We are
uniquely positioned to address genetic determinants of Fe homeostasis using a multidisciplinary approach. We
will first undertake a functional study to investigate population differences in non-heme Fe absorption in a large
cohort of East Asians (n=252) and Northern Europeans (n=252). Population differences in Fe absorption will
be evaluated in relation to a fixed level of Fe stores (Aim 1). Three hormones, hepcidin, erythroferrone and
erythropoietin, are now known to regulate systemic Fe homeostasis. In Aim 2, we will characterize these
hormones and additional hematological, and Fe status biomarkers in all 502 participants to develop models to
investigate variability in Fe absorption that can be captured by existing Fe biomarkers and regulatory
hormones as a function of age, gender and population. To fully capture known and novel genetic variations
underlying Fe absorption in different populations, genetic variants will be measured in all 504 participants in
Aim 1 using the Illumina Infinium BeadChip. We will investigate the genetic contribution to Fe absorption, Fe
status and Fe regulatory hormones and explore possible differences as a function of genetically confirmed
ancestry (Aim 3). Our approach thus has the potential to identify novel relevant Fe homeostatic pathways that
are associated with Fe status and more importantly that may be driving variability in Fe absorption, the key
regulatory site of Fe homeostasis. These studies will provide novel information on human dietary adaptation
that will shed light on the genetic basis of population discrepancy in traits and disease susceptibility, and will
guide future genome-informed nutritional practices.

Public health relevance
PROJECT NARRATIVE Genetic variation in human populations is increasingly recognized to contribute to individual phenotypic differences, variable metabolic traits and differential susceptibility to common chronic and metabolic diseases. Understanding genetic variations underlying metabolic traits is particularly important for iron (Fe), given that Fe deficiency remains the most widespread micronutrient deficiency worldwide, while Fe overload is thought to contribute to a number of common chronic diseases including type II diabetes, cirrhosis, cardiomyopathy and cancer. The proposed project will take a multidisciplinary approach to study genetic variations in genes that control Fe metabolism and utilization in order to shed light on the genetic basis of population differences in Fe metabolism and disease susceptibility and to inform population-specific dietary Fe intake recommendations with the long-term goal of minimizing risk of chronic diseases.